Point of Care maternal milk concentration device optimizing neonatal growth with targeted nutrition support: Establishing clinical evidence of benefit as an alternative to milk sourced fortification

Project Summary
Human milk is the best feeding option for preterm infants. However, to meet the high nutrient
needs of preterm infants in Neonatal Intensive Care Units (NICUs), mother’s own milk (MOM) is
often mixed with bovine milk sourced fortifiers to provide adequate nutrients for growth. The
Human Milk Concentration (HMC) device is the first of its kind a point of care medical device that
uses a gentle osmotic draw to remove water from milk so that preterm infants can receive optimal
nutrients as well as bioactives from their own mother’s milk without cow’s milk additives. This is
an innovation that embodies the NIH mission of improving healthcare outcomes by providing
preterm infants the valuable nutrients only found in mother’s milk, increasing their chance of
survival and improved overall health. The HMC device will increase feeding amounts of mother’s
own milk fed to preterm infants which impacts immune system, microbiome development and
even long-term health by decreasing risk of life-threatening diseases. Given the success of the
technology in concentrating mother’s milk and the progress made in the Phase II research, the
goal of this proposal is to perform the seminal clinical trial- a 3-site study with specific aims that
provide the quantitative evidence required for broad adoption and a paradigm shift in neonatal
feeding- the results of which will allow for the commercialization of the device. Mother’s Milk is
Best Inc (MMIB)’s Phase IIB objectives are Specific Aim 1) To determine through randomized
non-inferiority trial whether preterm infants fed exclusive MOM gently concentrated at point of
care will have growth and mineral status similar to infants fed the standard of care which is MOM
supplemented with cow’s milk-based products. Specific Aim 2) Assess the cost of feedings and
total cost of care using passive concentration of human milk fortifier versus cow’s milk fortifier
Specific Aim 3) Determine the best practices for NICU utilization of the human milk concentrating
device with parents and NICU staff members involved in human milk concentration during the
randomized, controlled trial
Once these objectives are met, Mother’s Milk is Best will have the scientific evidence of the HMC
benefits by enabling physicians to adopt the technology though a data-based decision, cost and
outcomes driven, accelerating the commercialization of this paradigm shift of the standard of care
for preterm infant feedings.

Public health relevance
Narra$ve The Human Milk Concentration (HMC) device will allow for exclusive mother’s own milk (MOM) and/or Donor Human Milk, when nourishing vulnerable preterm infants in need of high nutrient intake by fortifying feedings through the passive concentration allowing for the transfer of increased immune factors as well as nutrients to preterm infants. The proposed efforts described in this Phase IIb plan will provide the evidence: clinical, cost- benefit and acceptability demonstrating the effectiveness of the HMC – the final step required to prove the safety and efficacy of the device before commercialization. Success of this work will position this novel technology and approach to preterm infant feeding as a new standard of care- reducing illness and improving overall long-term health benefits for preterm infants through the ability to use more of mother’s own milk.